Small molecule screening for novel regulators of cardiac Ca2+ kinetics and rhythm

DESCRIPTION (provided by applicant): Tightly regulated Ca2+ homeostasis is essential for establishment of regular cardiac rhythm. Even a slight increase in cytosolic Ca2+ concentration can trigger fibrillation-like contraction and cardiac standstill in vivo and in vitro. Through zebrafish phenotype-based suppressor screening, we have recently identified a small molecule that restores fibrillation-like contraction of the heart. Biochemical analyses suggest that this compound binds to and potentiates a mitochondrial Ca2+ transporter, VDAC2. These data suggest a novel function of mitochondria as a fine-tuner of Ca2+ handling in the regulation of cardiac rhythmicity. Encouraged by the success of zebrafish screening, we propose to establish high- throughput screening system for forward chemogenetics approach to identify novel genetic pathways critical for the regulation of human cardiac Ca2+ homeostasis and rhythmicity using newly developed human embryonic stem cell- derived cardiomyocytes (hESC-CMs) differentiation protocol. Bioengineering approach, zebrafish in vivo heart and isolated adult mouse cardiomyocytes will be used as models to validate the hit compounds. We specifically propose to; 1. Assay development: We will optimize modalities to induce fibrillation, timing of the compound treatment, and readout for HTS. Efsevin will serve as a positive control. 2. Pilot screening: Pilot screening will be conducted with hESC-CM. 3. Hit validation: Once hits are identified, they will be tested on three model system. The long-term goal of this project is to establish a novel mechanism and treatment of atrial fibrillation, which affects 1% of total population older than 60 and 5% of 75 and older, and poses a high risk to stroke and other systemic emboli.

Public health relevance
PUBLIC HEALTH RELEVANCE: Deregulation of contractility and rhythmicity are the major causes of heart diseases and pose serious health threats. Based on the successful screening of anti-arrhythmic chemicals in zebrafish and establishment of efficient protocol of cardiac differentiation from human ES cells, we propose to use both the zebrafish and human ES cells as models to identify new targets for potential therapeutic strategies.